Functional Characterization of the Genetic and Environmental Determinants of Complex Traits

Abstract
Understanding the molecular and organismal function of genetic variants in non-coding regions is crucial to
dissect the genetic and evolutionary basis of variation in complex traits. As we and others have shown, the effect
of a genetic variant on a molecular pathway, and ultimately on the individual's phenotype, may be modulated
by the environmental context (gene-environment interactions, GxE). Most contexts considered to date focus
on aspects of the physical environment that can be reproduced in vitro (e.g., pathogen particles, hormones,
toxicants). We also pioneered the study of GxE with psychosocial experiences (e.g., socio-economic status,
neighborhood stress). Importantly, psychosocial experiences can inﬂuence an individual's ability to respond to
other environmental challenges and these effects can be measured at the cellular level. However the effects
of psychosocial experiences on the transcriptional response to cellular stressors has not been fully evaluated.
The response to environmental challenges is often mediated by changes in transcription factor activity. Single
cell genomics technology has allowed us to discover that gene regulatory changes in response to environmental
perturbations are often heterogeneous both across cell types, and across individual cells within a cell type,
resulting in a dynamic response. This dynamic response can in turn be regulated through GxE, and it's an
important contributor to disease risk. To study the dynamic gene regulatory response to chemical and social
stressors, here we will focus on peripheral blood mononuclear cells from an inner city cohort of middle-aged
adults collected as part of The Heart of Detroit Study (THDS) and consider psychosocial and cellular stressors.
One of the main objectives of this project will be to develop functional genomics, computational, and statistical
approaches to dissect the epigenetic mechanisms underlying the response to in vitro and in vivo stressors, their
interactions with genetic variants, and ultimately their role in complex trait variation. The tools developed in this
project will have broad applicability in the ﬁelds of functional genomics, systems biology, and GxE, ultimately
allowing for a global and integrative analysis of genetic and environmental effects on biological systems.

Public health relevance
Project Narrative The purpose of this project is to improve our understanding of the genetic and epigenetic mechanisms under- lying the response to psychosocial and cellular stress. This work will provide a useful resource to any researcher interested in gene-environment interactions in human complex traits, whether considering psychosocial or cellu- lar contexts.